Addressing Inactive Kidney Transplant Waitlist Status through Adapting a Tailored Psycho-Social-Environmental Program

PROJECT SUMMARY/ ABSTRACT
Kidney transplantation (KT) is a growing treatment for older adults with end-stage renal disease (ESRD), but
there is vast heterogeneity in KT outcomes. Older adults are more likely to be listed as inactive (on the waitlist
but ineligible for KT), which is associated with increased waitlist mortality and worse post-surgical outcomes.
Those awaiting KT also experience depressive symptoms, pain, loss of physical function, and social isolation,
which can contribute to waitlist mortality and decrease chances of KT. As of April 2022, 94,249 people were
awaiting KT with an estimated 44% currently inactive. There is a critical need for enhanced models of care to
improve inactive waitlist outcomes. The purpose of this study is to adapt and pilot test the evidence-based
Community Aging in Place- Advancing Better Living for Elders (CAPABLE) intervention to address barriers for
KT waitlist activation which involve symptom burden, self-management, social support, health literacy, patient
activation and home function. CAPABLE equips older adults to age in their homes using person-directed
priorities and a strengths-based tailored approach by a nurse, occupational therapist and handy worker (PI:
Szanton, co-primary mentor). CAPABLE improves function, pain, depressive symptoms, and quality of life
while decreasing hospitalizations and nursing home admissions. CAPABLE also improves healthcare
engagement and self-efficacy which are key components to remaining active on the KT waitlist. Our adapted
CAPABLE–Transplant model will extend services to include options for internet access, training, patient portal
usage and patient-directed online social engagement to address the noted isolation. We hypothesize that
decreasing patient and clinician reported barriers will decrease time inactive on the KT waitlist status. We plan
to examine CAPABLE-Transplant among those with inactive KT waitlist status in a two-phase developmental
study leveraging partnership with the JHU Comprehensive Transplant Center and an ongoing, prospective NIA
R01-funded cohort study of individuals awaiting KT for recruitment (PI: McAdams-DeMarco, co-primary
mentor) through the following aims: (1) To develop an adaptation of CAPABLE targeting those currently KT
inactive, (2) To iteratively refine the CAPABLE -Transplant prototype for those currently KT inactive and, (3)
To pilot test the CAPABLE-Transplant intervention in a 30 person 1:1 randomized waitlist control trial delivered
over 16 weeks with outcomes (e.g. waitlist status, symptom burden, social networks) evaluated at 0,16, and 32
weeks post-randomization to test feasibility, acceptability, fidelity of CAPABLE-Transplant and estimate
preliminary effects sizes for a future efficacy trial. To our knowledge, there are no other home-based programs
that address patient-directed goals and the home environment among those inactive awaiting KT. This work
will form the basis for a future R01 to expand to other KT centers and/or into other transplant populations
conducting a larger community-based, efficacy trial.

Public health relevance
PROJECT NARRATIVE Inactivity (currently ineligible for transplant) on the kidney transplant (KT) waitlist occurs in 44% of those awaiting KT, disproportionally affecting older adults and incurring greater risk of death and poor KT surgical complications in addition to the high symptom burden (pain, disability and depressive symptoms) already experienced by this population. The purpose of this study is to adapt and pilot test the patient-directed in the home, team-based (nurse, occupational therapist, handy worker) Community Aging in Place- Advancing Better Living for Elders (CAPABLE) intervention to decrease barriers like symptom burden and low health literacy and patient activation in order to lessen time inactive on the KT waitlist. The novel adaptation of CAPABLE to this highly vulnerable population may result in more equitable KT allocation and better patient outcomes while potentially saving money, all of which will be further explored in the resulting R01 application.